OHSU Women's Reproductive Health Research K12 Program

1. Summary. This application proposes to continue a multidisciplinary basic, translational, and clinical
research training and career development program, the Oregon Health & Science University (OHSU) Women's
Reproductive Health Research K12 Program, that will foster and cultivate a cadre of OB/GYN physicians to
transition into leading independent physician-scientists in women's reproductive health. The program builds
upon long-standing collaborations between the OB/GYN Department and prominent OHSU Centers, Institutes,
and Departments, including the Oregon National Primate Research Center, and Knight Cardiovascular and
Cancer Research Institutes, to provide a strong foundation for multidisciplinary training, mentorship, and
research.
The primary aim of the program is to produce highly-qualified OB/GYN researchers with a specific focus on the
reproductive life cycle spanning the preconception period (including family planning) to developmental biology
to pregnancy care and complications in both women and their offspring. The specific areas of emphasis would
be: (1) contraceptive development, effectiveness, and impact; (2) developmental origins of health and disease
(DOHaD) – fetal programming; (3) reproductive biology including ovarian and uterine function/dysfunction, the
developing embryo and fetus; (4) maternal physiology, pathophysiology, pregnancy care and complications,
and the outcomes of both women and their offspring.
Upon completion of the OHSU WRHR K12 Program, scholars will have expertise in research methods and the
skills required for success as academic physician-scientists in reproductive health. Scholars will develop
content expertise relevant to his or her research interests, along with the specific research skills appropriate to
that research topic as well as skills in scientific writing including grant writing and academic career
development. By the end of the training period, each scholar will be well-prepared to become independently
funded physician-scientists.
With this in mind, the OHSU WRHR K12 Program has the following Specific Aims:
Aim 1: Recruit, mentor, and train a diverse group of obstetrician-gynecologists to become reproductive
scientists and national leaders in women's health research.
Aim 2: Support and enhance a robust mentored research and training infrastructure that promotes the
development of reproductive physician-scientists.
Programmatic Success will be measured by:
1) Scholars transitioning to independent funding status
2) Scholars' research productivity
3) Scholars developing as overall academicians and leaders in Research and OB/GYN

Public health relevance
2. Project Narrative. We will continue a research training and career development program, the OHSU Women's Reproductive Health Research K12 Program, that will prepare obstetrician-gynecologists to become physician-scientists and develop independent research careers. It will be a multi-disciplinary effort pulling together mentor teams from throughout OHSU. The primary aim of the program is to produce highly qualified and independently funded OB/GYN researchers who will conduct research across the reproductive life cycle.